Anise Health: Culturally-Sensitive Digital Mental Health for Asian Americans

Abstract
The 22 million Asian Americans (AAs) are up to 5 times more likely to drop out of mental health
treatments prematurely and 50% more likely to report such treatment being ineffective
compared to their White counterparts. As such, AA young adults have been the only
racial/ethnic group with suicide as the leading cause of death. Since the onset of the pandemic,
AAs have experienced the greatest increase in the prevalence of depression and anxiety among
all racial/ethnic groups driven by the exponential rise in anti-Asian hate and violence, with 41%
of AAs reporting current anxiety or depression. However, 62% of AAs with current mental health
diagnoses do not have access to effective mental health services, due to a lack of
evidence-based methods for addressing cultural stressors in therapy. Despite the association of
deep-rooted systemic and interpersonal racism (e.g., perpetual foreigner stereotype and Model
Minority Myth) and bicultural tension widely experienced by AAs with poor mental health
outcomes, current evidence-based practices (“EBP”) are unable to effectively treat the impact of
such stressors for AAs. While efforts have been made to adapt EBP for certain minoritized
groups, none to date have been developed to address such stressors in therapy for AAs. Anise
Health is a pioneer in the technology-enabled delivery of culturally-adapted mental health care
for AAs. Preliminary data have demonstrated Anise’s ability to drive high patient engagement
and retention, resulting in statistically significant improvements in depression, anxiety, and
stress symptoms in just 8 weeks. We propose to challenge and innovate the current clinical
practice paradigms by creating accessible, culturally sensitive, and inclusive digital tools for
AAs. Aims: 1: Adapt and further develop evidenced-based, culturally-sensitive digital mental
health clinical tools that target the impact of race-based trauma and bicultural tension on mental
health outcomes for the AA community. 2: Assess clinician receptiveness and use of Anise’s
online platform tools for managing race-based trauma and bicultural tension with their AA clients
for eight weeks, and revise accordingly. 3: Evaluate the initial efficacy of the online platform
tools for managing the impact of race-based trauma and bicultural tension with 64 AA clients. A
successful outcome of this proposal will be digital materials that effectively address the impact
of race-based trauma and bicultural stress for AAs on Anise’s digital health platform. It will be
ready for a larger clinical trial and wider commercialization with partner institutions, which would
be the subject of a future phase II submission.

Public health relevance
Narrative There is a dearth of attention to Asian American (AA) issues in mental health research and clinical practices, resulting in underutilization of mental health services and low treatment adherence by AAs. This contributes to increased healthcare costs, significant health inequity, and worse quality of life. Evidence-based practices (EBP) in psychotherapy must be adapted to incorporate sociocultural factors such as race-based trauma and bicultural tension which have been demonstrated to negatively impact the mental well-being of AAs. Anise Health is pioneering the technology-enabled delivery of culturally-adapted mental health care for AAs. Anise is developing proprietary care models that incorporate cultural factors into EBP, a library of digital tools for providers and patients to leverage in treatment and provider training programs on culturally-sensitive clinical models and tools which will drive long-term clinical outcomes in mental health treatments for AAs.